Neuronal and behavioral effects of an implicit priming approach to improve eating behaviors in obesity

PROJECT SUMMARY/ABSTRACT
Weight loss is associated with a reduction in obesity-related health risks, but can be difficult, with preventing
subsequent weight regain even more challenging. As such, understanding mechanisms underlying energy
balance regulation and identifying strategies for successful weight loss and maintenance are important goals,
and are key components of the Strategic Plan for NIH Obesity Research.
Food intake is a complex process involving homeostatic signals (e.g., appetite-related hormones) and
non-homeostatic signals (e.g., reinforcing properties of food). One factor that may contribute to susceptibility to
obesity is a high responsivity to high-calorie foods, which promotes increased caloric intake. Food preferences
involve learned associations thought to develop via classical conditioning through repeated pairings with
external stimuli. Improving our understanding of the neuronal mechanisms underlying these processes and
attempting to modify them may be a useful strategy for weight loss and maintenance. Therefore, the proposed
study aims to investigate the neuronal and behavioral effects of an intervention designed to alter affective
associations with food, using a novel implicit priming (IP) paradigm, in which positively or negatively valenced
images are presented immediately prior to food images, but not consciously perceived. We hypothesize that IP
will alter neuronal and behavioral responses related to food intake, reducing the appeal of high-calorie foods
and promoting weight loss and maintenance.
The project goals are to further delineate the neuronal mechanisms underlying the intervention, establish
the impact of IP on longer-term food preferences and eating behavior, and determine if it can facilitate weight-
loss maintenance in individuals with overweight/obesity. Effects of IP on neuronal responses to visual food
cues and measures of eating behaviors (food intake, preferences) will be measured not only acutely, but also
following 12 weeks of weekly IP administrations, within the context of weight-loss maintenance. Weight and
body composition will be measured before and after the intervention, and, to assess lasting effects, 12 weeks
after the intervention has ended. Participants will be randomized to active IP, control IP (with scrambled
images as primes), or to an active control, cue exposure therapy (CET). Sex-based differences will also be
examined, as studies have observed women to have stronger, more frequent food cravings, greater neuronal
response to hedonic food cues, and greater sensitivity to disgust than men. The use of neuroimaging in this
study will provide a more sensitive measure than behavioral measures alone and will help to identify
mechanisms through which the intervention changes behavior. If the project aims are achieved, it would not
only yield new information about the neurobiology of food intake behavior, but also could represent a potential
novel intervention for treatment and prevention of obesity.

Public health relevance
PROJECT NARRATIVE Obesity is a significant public health concern associated with an overall increased risk of cardiovascular disease, type 2 diabetes, and mortality. The overall goals of this project are to determine the impact of an implicit priming intervention, designed to alter food perceptions, on brain responses to food, food intake behaviors and weight-loss maintenance in individuals with overweight/obesity. If the aims of the project are achieved, it would not only yield new information about the neurobiology of food intake behavior, but also could represent a potential novel intervention for treatment and prevention of obesity.